Development of Apo Mimetic Peptides for the Treatment Cardiovascular Disease

We previously showed that the 5A peptide can promote cholesterol efflux by the ABCA1 transporter and reduce atherosclerosis in animal models. The peptide was licensed to KineMed Inc, who received a RAID grant for performing preclinical toxicology studies, which have commenced. We have done additional structure function studies on the 5A peptide and identified 2 key hydrophobic residues in the hinge region of this bi-helical peptide for it to be able to promote cholesterol efflux. Based on this finding, we developed a new membrane solubilization model for how apolipoprotein mimetic peptides interact with membranes and promote cholesterol efflux.